Upstate New York Immunology Conference

SUMMARY
In an effort to provide a forum for immunologists (investigators and trainees) from the Upstate New York area
and surrounding regions to present and discuss their research and build collaborations, the Upstate New York
Immunology Conference was initiated in 1998 and initially included 53 participants from 3 institutions. This annual
meeting has now grown to include 13 institutions with current attendance of approximately 100 participants/year.
The specific objectives are: 1) to provide a forum for members of the regional immunology community to present
their work, exchange ideas, and develop collaborations; 2) to give students and postdoctoral fellows an
opportunity to meet distinguished scientific leaders in the field, as well as other trainees and PIs from area
institutions; 3) to give students and postdoctoral fellows an opportunity to present their work in a meeting format,
and obtain appropriate feedback on their projects; and 4) to increase local, national, and international awareness
of immunology research being conducted in the region. The meeting also addresses career issues through
workshops organized by attendees from NIH/NIAID and the keynote speakers. The next meeting will be held
October 17-20, 2022 at the Otesaga Resort Hotel, Cooperstown, NY. It is anticipated that there will be
approximately 100 participants from Albany Medical College, the New York Public Health Laboratories
Wadsworth Center for Research, SUNY Upstate Medical University, the University of Rochester, Cornell
University, Roswell Park Cancer Center, the University of New York at Buffalo, University of Connecticut,
Pennsylvania State University, the University of Vermont, McGill University, Ohio State University, and
Dartmouth Medical School. In addition, there will be two keynote speakers - Drs. De’Broski Herbert from the
University of Pennsylvania and Katrin Mayer-Barber from NIH/NIAID. There will also be an NIAID-organized
workshop related to grantsmanship, funding, and peer review. As in previous meetings, we will present 20 Young
Investigator Awards based upon outstanding abstracts selected by our Organizing Committee and Scientific
Advisory Board members from each of our 13 sponsoring institutions. All those wishing to attend will be
accommodated within the Otesaga Resort's 300 rooms and extensive conference facilities.

Public health relevance
PROJECT NARRATIVE The annual Upstate New York Immunology Conference, currently in its 24th year, provides a forum for immunologists (faculty and trainees) from the Upstate New York area and surrounding regions to present and discuss their research, and build collaborations.